SOFTWARE DISSEMINATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We have several software packages which are distributed freely from our web site http://ncmi.bcm.tmc.edu. In addition to formal releases, daily snapshot versions are available for most packages. Available software includes EMAN, EMAN2, SAVR, AIRS and SAIL. AIRS is currently distributed as part of EMAN.